Substance Abuse Intervention Outcome Research Training

SUMMARY/ABSTRACT
The aim of our multidisciplinary program is to train postdoctoral biomedical, behavioral, health care and other
public health scientists to conduct innovative and rigorous addiction treatment research. An overarching goal is
to enhance the scientific reasoning skills needed to advance treatment options for people who struggle to
reduce their substance use. From our perspective, such research will benefit from interventions guided by
sophisticated and fully developed theory using a multidisciplinary framework that includes the biological,
psychological, social, cultural, and policy context in which interventions occur. Distinctive features of our
training program are that it is interdisciplinary; that it embraces no single ideology or theory concerning the
nature of dysfunctions related to drug use; that it provides training in early intervention and treatment along a
continuum; and that it provides trainees with highly individualized opportunities to develop competitive grant
applications and by doing so, contribute to the knowledge base of substance-related dysfunction and
treatment. The training experience is structured to provide individualized research experience and training,
complemented by a core academic curriculum to which 20% of fellows' training time is allocated. Four distinct
areas are covered in the curriculum: (1) statistics/research methodology; (2) grantsmanship; (3) ethical issues
in research; and (4) a two-year series of formal courses covering the etiology and treatment of substance use
from varying disciplinary perspectives. We also subscribe to a research apprenticeship model under the
guidance of the research mentor. Each fellow's individual research training experience emerges from an
individualized development plan developed by the fellow, agreed to by their mentor(s), and reviewed and
approved by the Training Committee. The program has a primary emphasis on training in innovative treatment
development and clinical trials research with a secondary emphasis on the translation of clinical research into
services research. Our research in behavioral economics, neuroscience, and pharmacotherapy expands our
focus of translational research from basic to clinical. An additional area of prominence in our training program
is tobacco regulatory science. The typical training program duration is two years, but we offer a third year when
needed. The program accepts on average two new fellows per academic year.

Public health relevance
NARRATIVE This training program is designed to address the significant and costly public health problem of substance use disorders by training postdoctoral biomedical, biobehavioral, health care, and other public health scientists to conduct addiction intervention research. Our program draws on many scientific disciplines, including biological sciences, epidemiology and etiology, prevention, clinical, and public health research, and emphasizes multidisciplinary approaches to achieving innovations in addiction research. Cutting-edge training of the next generation of addiction researchers has the potential to accelerate the pace of science in developing effective treatments.